CFTR gene correction via targeted exon replacement

PROJECT SUMMARY
Cystic fibrosis (CF) is a life-threatening genetic disorder that affects >120,000 individuals worldwide. Mutations
in the CFTR gene cause CF, with 10% of people with CF (pwCF) having two copies of mutations that are unre-
sponsive to FDA-approved CFTR modulators. Exon 12 contains the most common modulator-ineligible mutations,
affecting nearly one in five pwCF who are not able to receive modulator therapies. This subpopulation of pwCF
urgently needs a corrective gene editing therapy to restore CFTR function. Gene editing the endogenous CFTR
presents a promising path to cure CF by correcting the pathogenic mutations. However, current approaches
face significant limitations: they target only one or few mutations at a time, demonstrate low efficiency and risk
unintended off-target effects. To overcome these barriers, this proposal aims to develop a new gene editing
strategy that replaces the entire exon 12 without a DNA break, termed retron editing. Successful completion
of the proposed aims will establish a retron editor that can safely and efficiently replace CFTR exon 12. More
broadly, successful retron-mediated exon replacement will transform the lives of pwCF and those with other rare
monogenic diseases.

Public health relevance
PROJECT NARRATIVE This project aims to develop a gene editing therapy that could offer a cure for cystic fibrosis (CF), a chronic and life-threatening disease affecting >120,000 individuals worldwide. If successful, I will develop a gene editing modality that will offer a potential cure for 20% of cystic fibrosis patients who do not have any therapeutic options, ultimately reducing healthcare costs and the burden of disease on affected individuals and families.